Coordinated mechanisms to rescue bioenergetics and sarcopenia in aging

PROJECT SUMMARY
A widely conserved hallmark of aging is the decline in muscle mass and strength, promoting frailty, loss of
independence and disability. Crucial for this is our gap in knowledge regarding mechanisms linking bioenergetic
stimulation to muscle anabolism. Glucocorticoid steroids have pervasive effects on energy metabolism and
muscle function. Dosing intermittence appears crucial to the benefits/risks ratio of these drugs in dystrophic
animal models and patients, i.e. in genetic myopathies. Here we investigate whether intermittent glucocorticoids
increase performance in aged muscle, where weakness and sarcopenia are not dependent on specific genetic
insults. Our new results in 24 months-old WT mice show that a chronic regimen of intermittent once-weekly
prednisone increased muscle performance in aging mice to levels comparable to young adult mice (4 months-
old). Remarkably, treatment rescued both mitochondrial respiration and muscle mass in aging mice to young-
like levels. Mechanistically, we found that bioenergetic, functional and anabolic effects of intermittent prednisone
were blunted upon inducible ablation of PGC1a in adult muscle. While the role of PGC1a in boosting
mitochondrial capacity in aged muscle is more established, its effects on age-related sarcopenia and weakness
are still debated with conflicting results from constitutive knockout or overexpression models. Scattered reports
have hinted at a role of PGC1a in activating growth pathways, including biosynthesis of amino acids like alanine,
but this is still largely unknown in muscle aging. Here we will investigate the mechanisms through which a
bioenergetic stimulation like intermittent prednisone rescues both oxidative metabolism and mass gain in muscle
aging. In Aim 1, we will determine the extent to which intermittence discriminates deleterious versus beneficial
effects of glucocorticoids in aging muscle. We hypothesize that dosing intermittence shifts exogenous
glucocorticoid effects from a PGC1a-lowering pro-wasting program to a PGC1a-dependent pro-ergogenic
program, i.e. balanced gain of performance and mass. We will test this through inducible muscle-specific PGC1a
ablation after natural aging. In Aim 2 we will establish the role of muscle Lipin1 in PGC1a re-activation in muscle
aging. We hypothesize that Lipin1 supports mitochondrial function in muscle aging and mediates the PGC1a re-
activation in response to intermittent glucocorticoids. To test this, we will use our newly derived mice with muscle-
restricted inducible Lipin1 ablation after natural aging. In Aim 3, we will elucidate the extent to which bioenergetics
rescue sarcopenia in aging through amino acid biosynthesis. We hypothesize that mitochondrial reactivation
fuels amino acid biogenesis, supporting protein synthesis during muscle aging. We will test this by tracing
glucose-derived carbons into amino acids in oxidative versus glycolytic myofibers. We will also test the extent to
which muscle PGC1a mediates these effects in young versus aging muscle. In summary, here we leverage the
unprecedented effects of intermittent glucocorticoids to discern unrecognized mechanisms of aging physiology
and rejuvenate muscle bioenergetics and anabolism.

Public health relevance
PROJECT NARRATIVE A widely conserved hallmark of aging is the decline in muscle mass and strength, which promotes frailty, loss of independence and disability. Based on new evidence we garnered in aging WT mice and mice with muscle- specific inducible PGC1a ablation, we hypothesize that the bioenergetic stimulation induced by intermittent glucocorticoid dosing rescues aging muscle quality through a coordinated action on mitochondrial dysfunction and sarcopenia. We will use our newly generated inducible transgenic models to establish the previously unrecognized roles of mitochondrial regulators PGC1a and Lipin1 in aging physiology through ablation AFTER natural aging.